Sexual and Gender Minority Cancer Curricular Advances for Research and Education (SGM Cancer CARE)

A health workforce trained to conduct sexual and gender minority (SGM)-inclusive cancer research is needed
for SGM persons seeking comprehensive cancer care, including prevention, screening, treatment, and
survivorship care. Research on SGM populations has described many SGM cancer disparities. A growing
number of studies of SGM individuals have documented increased exposure to cancer risk factors and certain
cancers, as well as poorer cancer outcomes. Moreover, SGM groups are highly diverse, presenting with
unique and varied care needs. Although the body of research focused on SGM populations continues to grow,
gaps persist in the knowledge of specific SGM cancer risk factors and cancer treatment experiences critical for
developing evidence-based interventions to optimize oncology care across the cancer care continuum—from
prevention to survivorship. As no nationally available resource routinely trains and prepares the oncology
and biomedical workforce for SGM cancer research, our short-term goal is to establish and promote a
foundational curriculum, SGM Cancer CARE (Sexual and Gender Minority Cancer Curricular Advances
for Research and Education), that recruits and orients early-career and junior investigators to SGM
cancer research and fosters productive collaborations. The curriculum has been designed by a multi-
disciplinary, multi-institutional project team and expert advisory committee that bring national perspective and
experience with SGM populations and in-depth knowledge across key areas, including cancer research,
clinical care, curriculum development, and health care advocacy. Specific Aims: (1) Offer the SGM Cancer
CARE course annually to 30 early-career investigators recruited nationally from a broad audience of
professionals interested in SGM cancer research using a specialized curriculum, multimodal delivery
strategies, networking tools, and innovative teaching methods; (2) Facilitate professional development and
research success for participants by providing orientation and post-workshop seminars to complement the
SGM Cancer CARE course. These sessions will focus on new topics in under-studied areas of SGM cancer
research, as well as provide participants with exposure to potential SGM research mentors and career
development guidance; and (3) maximize the efficacy of the course by evaluating and updating curricular
enhancements and teaching innovations for multimodal dissemination. Core modules include clinical cancer
research, behavioral sciences and interventions, epidemiology and population-level research, community-
based participatory approach for SGM cancer research, data collection and mHealth/eHealth platforms, and
advancing SGM research(ers). This course design will be adaptable for in-person modality, blended learning,
and/or online-only formats in response to the research and education restrictions related to the COVID-19
pandemic. The long-term goal of the SGM Cancer CARE course is to increase the number of professionals
able to lead and advocate for research to reduce SGM cancer disparities and to advance SGM health equity.

Public health relevance
PROJECT NARRATIVE Better understanding by researchers and cancer care providers of the unique health needs of sexual and gender minority (SGM) individuals could markedly reduce cancer risk and/or improve experience along the cancer care continuum, from prevention to survivorship. In this project, we will establish and promote a foundational course to help prepare early-career researchers who are developing their research agendas to engage in cancer research relevant to SGM groups. This innovative course will provide an overview of knowledge gaps and challenges in SGM cancer research, strategies and resources to address these issues, and opportunities to network with researchers with shared interests who will serve as role models, mentors, and collaborators, thereby enhancing participants' understanding and abilities to successfully engage in SGM cancer research.